Federal Cervical Cancer Collaborative

The purpose of this project is to develop a comprehensive learning series for HRSA and other safety net settings of care to strengthen cervical cancer prevention, screening and management using the project ECHO remote learning series model. In addition to developing and delivering the learning series, the contract is to promote, conduct/lead, and evaluate the Development and Delivery of a Cervical Cancer Prevention and Management Learning Series for Safety-Net Settings of Care. This will include a ten (10) month remote learning series and related curriculum for safety-net setting of care providers to strengthen cervical cancer prevention, screening, and management.